Glycine subunit specific inhibition and ganglion cell visual responses

Retinal ganglion cells (GCs) integrate excitatory and inhibitory inputs and perform computations that encode
diverse features of the visual scene. The output of these functionally and morphologically diverse GCs establish
visual signaling streams, maintained throughout the visual pathway. Ultimately, they create our perception of the
size, shape and color of objects and their relationships in space. They establish relationships of objects in time, so
that we know when it is stationary or moving, and when moving, its direction and velocity. To this end, there is a
general division of labor between the retina's inhibitory neurotransmitter systems. GABA, and its receptors,
modulate spatial vision, whereas glycine, and its receptors, modulate temporal vision. There are five glycine
receptor subunits (one β and 4αs). The GlyRα subunits combine with a single β subunit to make functional
receptors with diverse biophysical properties. Our work shows that all GCs expresses one or more GlyRα’s and the
composition differs across GC type. We hypothesize that variety enhances the diversity of inhibitory functions across
and within GC types and are used to encode the visual scene. However, the specific function of GlyRα subunits is
almost completely unknown.
We know that the responses (and transmitter release) of the GABA and glycinergic amacrine cells presynaptic
to GCs are modulated by other glycinergic amacrine cell input. This means that until GlyRs can be selectively
eliminated in GCs or ACs, we cannot disambiguate the role of direct GlyRα inhibition to GCs from GlyRα modulation
in the upstream circuit that provides input to the GCs. We developed a novel AAV-shRNA knockdown (KD)
approach that eliminates expression of individual G lyRα subunits in GCs, while leaving their upstream expression
intact. We propose to use this approach to define the role of GlyRα direct inhibition in 7 identified GC types and by
extension the role of isolated GABA inputs in those same GCs. In Aim 1 we ask if a single GlyRα, GlyRα1 expressed by the 4 functionally diverse αGCs modulates the same or different aspects of their visual responses. In aim 2 we ask if
two different GlyRα subunits, expressed in the same GC, increase the diversity of inhibition to modulate different
aspects of the visual response in a single GC type. We use electrophysiological assays to characterize the spiking
responses of the GCs, underlying currents and the relationships between the kinetics of excitatory and inhibitory
input with the postsynaptic response.
This proposal addresses the novel concept: that diverse glycine subunit specific inhibition interacts with
presynaptic inputs to controls visual computation.

Public health relevance
The visual scene contains multiple streams of information that are efficiently processed and categorized by the retina. The spatio-temporal responses of GCs require the correct integration of bipolar cell excitatory and amacrine cell inhibitory inputs to GC. This project will define how diverse inhibitory inputs are shaped and how they are matched with excitation, which results in the accurate representation of the visual scene that is proved by the retina to the rest of the central nervous system.